The Function and Mechanisms of Voltage-Gated Proton Channel Hv1 in Spinal Cord Injury

Project Summary
Despite considerable research over the past 30 years, there is still no established effective treatment to
improve recovery following spinal cord injury (SCI). In part, this reflects incomplete understanding of the
complex secondary pathobiological mechanisms involved. The aim of our research is to understand the cellular
and molecular mechanisms responsible for post-injury neuroinflammation in order to allow future development
of novel therapies. The voltage-gated proton channel Hv1 is a newly discovered ion channel, highly expressed
in resting microglia of the brain. Under pathological conditions, microglial Hv1 is required for NADPH oxidase
(NOX)-dependent generation of ROS (reactive oxygen species) by providing charge compensation for
exported electrons and relieving intracellular acidosis. Thus, Hv1 is a unique target for controlling multiple NOX
activities and ROS production. However, neither the precise signaling mechanisms underlying this finding nor
critical role of Hv1 in the pathophysiology of SCI are fully understood. Based on our preliminary data, we will
test the hypothesis that microglial Hv1 functions as a key mechanism in neuroinflammation, through altered
NOX2/ROS/IFN- signaling that modulates microglia-astrocyte interaction, thus affecting long-term
neurological outcomes after SCI.
We will use systemic or microglial Hv1 KO, microglial NOX2 KO transgenic mice and in vivo and in vitro
innovatively technologies to determine the mechanisms of SCI-triggered Hv1 elevation on post-injury
neuroinflammation. Aim 1 will determine the function and mechanisms of the Hv1 in neuroinflammation
after SCI. Multiple quantitative assessments of microglia-mediated neuroinflammation will be combined with
genetic or pharmacological intervention targeting Hv1 to test the hypothesis that SCI-induced microglial Hv1
activation mediates detrimental neuroinflammation and functional deficits through altered microglial
NOX2/ROS signaling. Aim 2 will elucidate the role of microglial NOX2 in post-injury neuroinflammation.
We will utilize genetic intervention to delete Hv1-dependent up-regulation of NOX2 in microglia, and evaluate
the effects on microglial NOX2 coupling to Hv1 on neuroinflammation after SCI. Aim 3 will identify critical
role of Hv1/NOX2-derived ROS/IFN- in SCI-chronic neuroinflammation through microglia-astrocyte
interaction. Complimentary cellular, molecular, and genetic approaches will be used to test the hypothesis
that Hv1/NOX2-mediated microglial ROS activates pro-inflammatory astrocytes resulting in secreting IFN that
in turn reinforces microglial inflammation, thus contributes to astrocytes dysfunction and neuronal damage.
Our study will be the first to implicate microglial Hv1/NOX2/ROS/IFN- signaling in the pathophysiology
of SCI, leading to novel treatment approaches for SCI. Given the proposed roles for Hv1 in other inflammatory
models, Hv1 signaling represents a generic mechanism relevant to other neuroinflammatory states.

Public health relevance
Project Narrative Spinal cord injury (SCI) causes major neurological impairments including long-term sensorimotor deficits and posttraumatic neuropathic pain, with no effective treatment. The aim of our research is to understand the cellular and molecular mechanisms responsible for post-injury neuroinflammation in order to allow future development of novel therapies. In particularly we will target the signaling pathway of the voltage-gated proton channel Hv1, one of major ion channels expressed in resting microglia of the central nervous system, in order to decrease damage and increase functional recovery after SCI.